Glucan Particles as a Vaccine Platform for Protective Immunity

DESCRIPTION (provided by applicant): This proposal is focused on developing glucan particles (GPs) as a novel vaccine platform and adjuvant that promotes protective T cell and antibody responses. GPs are hollow, highly purified yeast cell walls composed predominantly of β-1,3-glucan. Preliminary studies demonstrate robust and long-lasting adaptive T cell and antibody responses following immunization of mice with GPs loaded with antigen. Moreover, mice vaccinated with GPs containing antigen from Histoplasma capsulatum (Hc) survive otherwise lethal experimental histoplasmosis. The experiments will address the central hypothesis that antigen-loaded GPs make effective vaccine platforms by alerting the immune system to the presence of danger, directing antigens into DCs and stimulating protective adaptive T and B cell responses. It is further hypothesized that the immune response can be beneficially manipulated by the addition to the GP platform of other adjuvants, such as TLR agonists and siRNA targeting negative regulators of inflammation. Aim 1 is to decipher the afferent pathways stimulated by GPs that shape T cell and antibody responses. The hypothesis to be tested is administration of GPs containing encased Ag results in complement activation, uptake by DCs via complement receptors and Dectin-1, migration of DCs containing GPs to draining lymph nodes and stimulation of a robust adaptive immune response including antibody and Th1/Th17-biased CD4+ T cell responses. Aim 2 is to investigate the efferent mechanisms by which fungal antigens complexed in GPs protect against Hc infection in mice. The hypothesis to be tested is uptake of antigen-bearing GPs by DCs shapes the immune response to generate a protective Th1 and/or Th17 response. Aim 3 is to explore novel approaches to boosting the immunogenicity of the GP platform. The hypothesis to be tested is the capacity of GP-formulated vaccines to protect against challenge with Hc can be augmented by specific stimulators of the innate immune response. We anticipate that at the end of the funding period, we will have created GP-based vaccines using FDA- approved materials capable of eliciting robust and durable antibody and Th1-/Th17-biased responses that protect immunocompetent and immunocompromised mice against challenge with Hc. Moreover, we anticipate that by altering the composition of the vaccines (such as by the addition of TLR ligands or siRNA), we will positively impact the nature of the responses. The studies address an NIH-identified need for development of a vaccine to protect immunocompromised and immunocompetent individuals in endemic regions from histoplasmosis. In addition, the studies should establish a proof of principle regarding the efficacy of GP-based vaccine platforms that should be applicable to other vaccine-preventable diseases and form the basis for eventual testing in humans.

Public health relevance
PUBLIC HEALTH RELEVANCE: A major challenge in vaccine research is discovering new antigen delivery systems that stimulate immune responses that protect at risk populations from deadly diseases. This proposal is focused on the development of a novel vaccine platform consisting of yeast-derived glucan particles that can be loaded with antigens and immune stimulants. The glucan particle vaccines will be tested for their capacity to elicit antibody and T cell responses and to protect against histoplasmosis, a fungal infection for which a vaccine is not presently available. __SpecificAimsTextDelimiter__ Specific Aims. Most licensed vaccines work by promoting protective antibody (Ab) responses. However, some populations, such as the elderly and the immunocompromised, generally have poor Ab responses to conventional vaccines. Moreover, for many infectious and neoplastic diseases, vaccines that arm adaptive T cell responses appear necessary. Thus, a major challenge in vaccinology is the development of platforms and adjuvants that effectively promote protective T cell and Ab responses. This proposal is focused upon the development and implementation of glucan particles (GPs) as a novel vaccine platform. GPs are hollow, highly purified microcapsules prepared from Saccharomyces cerevisiae cell walls. GPs are composed predominantly of β-1,3-glucan and are recognized by β-glucan receptors (particularly Dectin-1) on dendritic cells (DCs) and other phagocytes. GPs also potently activate complement, resulting in opsonization and recognition by complement receptors. We have demonstrated robust and long-lasting antigen (Ag)-specific T cell (Th1- and Th17-biased) and Ab responses following immunization of mice with GPs "encapsulated" with Ag. Moreover, vaccination with GPs containing a recombinant Ag, hsp60, from the pathogenic fungus, Histoplasma capsulatum (Hc), potently protects mice against lethal histoplasmosis. The proposed experiments are designed to expand upon these observations by addressing the central hypothesis that Ag-loaded GPs make effective vaccine platforms by alerting the immune system to the presence of "danger", directing Ag into DCs and stimulating protective adaptive T and B cell responses. We further hypothesize that the qualitative and quantitative nature of the immune response can be beneficially manipulated by the addition to this platform of immunoenhancing agents including TLR agonists and siRNA targeting negative regulators of inflammation. There are three interrelated specific aims: Aim 1: To decipher the afferent pathways stimulated by GPs that shape T cell and Ab responses. We have demonstrated that mice vaccinated with Ag encased in GPs develop strong T and B cell adaptive responses. However, many important aspects regarding how and why this happens remain undefined. Moreover, translation to the clinical arena will require formulations that are safe and efficacious in humans. We hypothesize that administration of GPs containing encased Ag will result in complement activation, uptake by DCs via complement receptors and Dectin-1, migration of DCs containing GPs to draining lymph nodes and stimulation of a robust adaptive immune response including Ab and Th1/Th17-biased CD4+ T cell responses. Projects include: 1) constructing GP-based vaccine formulations using pharmaceutical-grade materials generally regarded as safe (GRAS) for human use; 2) defining the nature of the T cell and Ab response to the GP-based vaccines; 3) characterizing the contributions of Dectin-1 and complement to promoting adaptive immune responses; and 4) defining the early events leading to initiation of immune responses following injection of GP-based vaccines. Aim 2: To investigate the efferent mechanisms by which fungal Ag complexed in GPs protect against Hc infection in mice. In preliminary studies, we have demonstrated that mice vaccinated with Ag encased in GPs are protected against lethal mycoses. However, the requirements for protection and the mechanistic basis by which protection occurs remain to be determined. We hypothesize that the uptake of Ag-bearing GPs by DCs shapes the immune response to generate a protective Th1 and/or Th17 response. Projects include determining the: 1) optimal requirements for vaccine-induced protection; 2) cellular soluble mediators that are modulated during the effector phase of infection; 3) functional importance of particular soluble mediators and cellular populations in the efferent limb; and 4) requirements for T cell subsets and memory cells in vaccine- induced immunity. Aim 3: To explore novel approaches to boosting the immunogenicity of the GP platform. Concomitant stimulation of distinct innate immune pathways can lead to improved adjuvanticity compared with triggering only an individual pathway. We hypothesize that the capacity of GP-formulated vaccines to protect against challenge with Hc will be augmented by specific stimulators of the innate immune response. Projects include examining the effect of addition of the following to GP-based vaccines: 1) TLR9 agonist, CpG DNA; 2) siRNA directed against A20, a negative regulator of inflammatory pathways; and 3) ISCOMATRIX adjuvant. We anticipate that at the end of the funding period, we will have created GP-based vaccines using FDA- approved materials capable of eliciting robust and durable antigen-specific antibody and Th1-/Th17-biased responses that protect immunocompetent and immunocompromised mice against challenge with Hc. The studies address an NIH-identified need for development of a vaccine to protect immunocompromised and immunocompetent individuals in endemic regions from histoplasmosis. In addition, the studies should establish a proof of principle regarding the efficacy of GP-based vaccine platforms that should be applicable to other vaccine-preventable diseases and form the basis for eventual testing in humans.